Core B: Lipodomics Core

Abstract
The purpose of the Lipidomics Shared Resource Core (LSR Core) in the PPG is to provide
intellectual and physical resources (particularly state-of-the-art mass spectrometry analysis of
sphingolipids and flux analysis) to enhance our understanding of the role of bioactive lipids in
cancer biology with the goal to discover future drugs. The diversity of bioactive lipids and their
interconnected metabolism generates a network of pathways regulating intra- and inter-cellular
signaling and function. Dysfunctions in these pathways contribute to the pathobiology of cancer
progression and metastasis, the study of which is the main goal for the four experimental projects
in this PPG. The vast diversity in sphingolipids with non-redundant, but often opposite functions,
has resulted in a necessity for the development of new protocols and analytical methods for their
identification and quantification. Appreciation for the depth of complexity involved in sphingolipid
metabolism and signaling has recently expanded since (i) same species of sphingolipids could
act differently depending on the subcellular compartment and (ii) variations in the acyl chain length
or saturation status could lead to specific biological responses. These two new considerations
exponentially increase the complexity on sphingolipid studies, and they have not been able to be
interrogated until now. The LSR Core was created based on unique expertise of the key personnel
in lipid chemistry, analysis, and metabolism, and it has evolved into a key Core for the program
project grant (PPG) entitled Sphingolipids in Cancer Biology and Therapeutics. Furthermore, this
Core has developed into an institutional, national, and international resource in the emerging
fields of lipidomics and lipid chemical biology. Core services include: 1) qualitative and
quantitative analysis of lipid components from different biological materials (cells, tissue, and
biological fluids), primarily employing high performance liquid chromatography-tandem mass
spectrometry (HPLC-MS/MS) technology—the Core currently provides quantitative analysis of
more than 300 distinct lipid molecular species at a basic metabolomic level; 2) development of
biochemical tools to study lipid metabolism (e.g., Sphingoproteomics, Sphingolipid Flux Analysis
utilizing a Pulse-Chase of non-natural C17-sphingolipids, functionalized and fluorescent
ceramides, site-specific radioactive sphingolipids); and 3) assisting PPG investigators in
experimental design, selection of appropriate methods, and interpretation of analytical results.
The LSR Core has been instrumental to the success of the PPG investigators over the past 16
years by providing them with unique capabilities and critical results that will continue to ensure
the successful progress of this PPG.

Public health relevance
PROJECT NARRATIVE This Core serves as an analytical platform to simplify the study of a large family of lipids (sphingolipids), and their metabolizing enzymes. These are key analysis for all the experimental projects in this PPG. Using targeted mass spectrometry, the core provides unique well stablished and consolidated methods to measure the more than 300 individual different species of sphingolipids, home-developed methods to monitor the enzymatic activities and the protein levels of the enzymes involved in the metabolism of these lipids. To facilitate the study of the role of sphingolipids in cancer, this core provides intellectual support on the experimental design and post data processing and data interpretation to the investigators. This close interaction between the core and the PPG investigators allow efficient adaptability from the Core to the needs of each project and their interconnection.